TRAINING PROGRAM IN ANESTHESIOLOGY RESEARCH

Abstract
This application seeks to renew the funding for the T32 training program at Washington University for physician
and doctoral scientists pursuing a career in anesthesiology-related research. The practice of anesthesiology is
complex and far reaching. The research interests of anesthesiology span this broad clinical realm and have the
potential to impact medicine as a whole. Developments in basic and clinical science have made the fundamental
unsolved problems in anesthesiology research scientifically tractable. Despite the potential of its research
programs for broad scientific and therapeutic impact, anesthesiology lags behind other specialties in training
physicians and basic scientists in research. Our program is directed at meeting this need. The overarching goal
is to train a diverse group of anesthesiology scientists with appropriate scientific skills to address the research
priorities in anesthesiology-related science. To accomplish this, we focus on: (i) recruiting and training a diverse
group of talented early stage anesthesiology scholars; (ii) identifying training opportunities in high priority and
high yield scientific areas; (iii) providing expert, accountable and dedicated research mentorship; (iv)
programmatically and systematically enhancing research training; (v) assessing trainee’s personalized goals and
progress; (vi) providing state-of-the art curricula and facilities as well as networking and educational
opportunities; and (vii) providing ongoing mentoring to T32 alumni to facilitate their transition to careers as
independent investigators. The Washington University Anesthesiology Department is among the highest funded
and most research productive anesthesiology departments in the United States. T32 trainees in the
Anesthesiology Department are typically selected from a cohort of research residents, which is one of the largest
nationally, based on the vibrant and highly effective Academic Scholars Advancement Program and the Scholars
track. Graduates from our T32 have published high impact research, obtained competitive training grants, and
continued in academic faculty appointments. Two program directors (PDs), an associate program director (APD)
and an executive advisory committee (EAC) administer the training program. Mentors for the program have been
carefully chosen based on the quality and relevance of their science and demonstrated mentorship experience
and success. Trainee-mentor pairing is facilitated and approved by the PDs, APD and EAC. Trainees and
mentors are formally evaluated twice annually for progress and satisfaction. Emphasis during these evaluations
is placed on progress towards development of an independent research program, acquisition of career skills and
attaining milestones such as manuscript and grant submissions. The PDs, APD, EAC and the trainees evaluate
the training program annually, and make ongoing recommendations for improvements. Our program also plays
a leadership role in the Early Stage Anesthesiology Scholars (eSAS) initiative and in collaborative ventures with
other national T32 programs. Therefore, our T32 trainees also develop key networking and leadership abilities.

Public health relevance
Narrative Anesthesiology has an increasing impact on overall patient care and outcomes through a comprehensive perioperative care model. However, anesthesiology research to improve perioperative patient outcomes is limited by the number of well-trained scientists and physicians devoted to anesthesiology research. This T32 program is aimed at increasing the number of well-trained anesthesiology researchers by supporting a formal training program in anesthesiology research at Washington University, which has one of the largest anesthesiology research programs in the US.